Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT - ABSTRACT
Connecticut residents are diagnosed with approximately 21,622 cases of cancer each year. Yale Cancer Center
(YCC) is the state’s only comprehensive cancer center and provides high quality cancer care, clinical trial access,
and cancer knowledge and tools for prevention and early detection to all 3.6 million CT residents within a 60-minute
drive. State cancer incidence rates are higher than national incidence rates and overall cancer burden is shaped by
structural and social factors—beyond individual level risk factors—such as income inequality, residential segrega-
tion, and differential utilization and availability of preventive care. YCC priority areas, influenced by catchment area
data and concerns, were selected to have the most impact on statewide cancer burden. The priority areas include
breast, liver, lung, and prostate cancers as well as cross-cutting themes of brain metastases, early onset cancers,
drug resistance, obesity and metabolism, and tobacco use. COE has also prioritized four micro-catchment popu-
lations—urban core areas, specific age groups (adults < 50 years & older adults), people who identify as Puerto
Rican, and Windham County—for outreach and engagement, based on sociodemographic and risk factor data,
and partners (established and emerging) capable of accelerating reach among these populations.
YCC’s Community Outreach and Engagement (COE) component uses relationships and data-driven approaches
to facilitate and advance equitable and catchment area-responsive research across the cancer care continuum. The
YCC COE vision is to deploy community outreach and engagement to ameliorate cancer burden within and beyond
YCC catchment area communities and to advance health equity. YCC COE advances this vision through four aims
focused on: 1) catchment area-driven discovery, 2) collaborations with YCC members to enrich research practice
and training relevant to catchment area populations including the diversification of cancer clinical trials, 3) elevating
community and patient voices within research and critical trust-building conversations that influence care, and 4)
disseminating scientific information and evidence-based practices to community organizations and catchment area
residents. COE aims are realized through four innovative signature programs developed through the infrastructure
and procedures established by COE. The four signature programs are: 1) Community Research Catalyst Program,
2) COE Liaisons Program, 3) Community Research Fellows (CRF), and 4) Community Champion Partnerships
(CCP). Signature programs have been organized within broader in-reach and outreach strategies to facilitate align-
ment of catchment area needs and YCC research priorities. The signature programs provide a focal activity within
each COE aim to facilitate catchment area-relevant research and bidirectional communications about catchment area
cancer burden and the potential benefits of YCC science to help address cancers in Connecticut. Selected impact
stories help illustrate the signature programs and early effects of COE investments on YCC research.

Public health relevance
COMMUNITY OUTREACH AND ENGAGEMENT – NARRATIVE Not applicable.